Biospecimen Core

ABSTRACT – Biospecimen Core
The Biospecimen Core is essential for the acquisition of all biospecimens, verification of “normal healthy tissue”
diagnosis, processing and allocation of all tissue and associated biofluids/non-tissue specimens required for
SCENT. Integration of multiple, well-established Duke institutions with highly specialized collaborative
capabilities is a unique strength of this Core. We are a nationally recognized biorepository and one of the highest
organ transplantations centers in the country. Biobanking activities occur in parallel with standard of care
biopsies, scheduled surgical procedures, autopsies and organ donor procurements. The objective of this Core
is to provide biospecimen services with exceptional quality control measures to enable tissue mapping of cellular
senescence biomarkers in normal healthy tissues across the lifespan (fetal/perinatal to elderly). This Core will
be led by a team with expertise in autopsy, organ donor and surgical tissue procurement. To accomplish our
goals, we will work to 1) efficiently identify, procure and verify diagnoses of high-quality normal healthy tissue
and concurrent biofluids/non-tissue specimens based on stringent criteria, 2) process high-quality normal healthy
tissues for correlative analyses and 3) ensure quality assurance and quality controls for sample management,
specimen tracking and biobanking informatics management for optimal banked tissue sharing for all SenNet
funded institutions. Our long-term goal is to constantly evolve to meet the needs of our investigators, either
through regulatory modifications, logistical modifications, additions to the service menu, or in creating solutions
to challenging research problems.